Role of RNA-binding protein in immune evasion of Mtb in macrophages

Project Summary/Abstract
Tuberculosis (TB) remains a leading global health problem with about 9 million new cases and nearly 1.5
million TB-related deaths worldwide each year. Mycobacterium tuberculosis (Mtb) infection persists in
macrophages when the host immune response is suppressed or evaded. However, mechanisms of TB immune
evasion remain incomplete. Better understanding the mechanisms will facilitate development of host-directed
therapy (HDT), especially against deadly drug-resistant Mtb. Our preliminary data indicate that an RNA-binding
protein, tristetraprolin (TTP) facilitates evasion and can be a target for host-directed TB therapy. TTP is an RNA
-binding protein involved in the regulation of inflammatory responses at the post-transcriptional level. TTP binds
to adenine-uridine-rich elements (AREs) within the 3’ untranslated region (3'UTR) causing destabilization of
mRNAs encoding several cytokines important for Mtb clearance, and has been shown by us and others to be an
important regulator maintaining homeostasis. Whether TTP affects Mtb replication or reactivation, however,
remains unknown. We found for the first time a significant TTP induction in lungs of Mtb-infected wild type mice
and in macrophages infected with mycobacteria, and deleting TTP resulted in suppression of mycobacterial
growth in macrophages. Further, mice deficient in TTP challenged with live Mtb had significantly less bacteria in
lungs than infected wild type littermates. TTP mRNA levels were significantly higher in caseous granulomas of
TB patients than in normal lung parenchyma. Reactivation and transmission of TB involve developing caseous
granulomas that cavitate and release Mtb. In addition, our data show for the first time that inhibition of mTOR
signaling by rapamycin almost completely abolishes TTP induction in Mtb-infected macrophages. Based on our
findings, we propose a novel role for mTOR/TTP axis in TB immune evasion: Virulent Mtb activates mTOR
pathway that induces TTP, resulting in suppression of anti-TB immunity, Mtb replicates and primary and/or latent
reactivation diseases. TTP may serve as a target to reverse immune evasion of Mtb. We propose two aims to
test this novel hypothesis: Aim 1. Determine the role of TTP in macrophages for mTOR-mediated Mtb growth
and the effects of targeting TTP on Mtb growth for potential host-directed therapy. Aim 2. Explore the molecular
mechanisms of TTP induction by Mtb in macrophages. Identification of the mechanisms of TTP induction will not
only enhance our understanding of Mtb evasion mechanisms, but also provide targets that can be used to
develop host-directed therapy breaking TB evasion. Results of these exploratory and mechanistic studies will
provide a better understanding of TB immune evasion mechanisms and potentially lead to TTP-targeted therapy,
especially with drug-resistant Mtb.

Public health relevance
Project Narrative Mycobacterium tuberculosis (Mtb) infection persists in macrophages by evading host immune surveillance. Our preliminary data reveal a new evasion mechanism of Mtb “virulent Mtb activates mTOR pathway that induces TTP, resulting in suppression of anti-TB immunity, Mtb replicates and primary and/or latent reactivation disease. This study will provide a better understanding of TB immune evasion mechanisms and potentially lead to TTP- targeted therapy, especially with drug-resistant Mtb.